Annual Meeting of the Association for Chemoreception Sciences (AChemS)

The objective of this conference grant request is to continue to provide support for aspects of the annual meeting of the Nation’s major chemical senses research society, the Association for Chemoreception Sciences (AChemS) for the next 5 year period. The specific objective is to bring outside scientists to the meeting to catalyze cutting edge interdisciplinary and translational research to accelerate discovery in the chemical senses.

Public health relevance
The chemical senses play a role in socially relevant major diseases associated with the regulation of food intake -including diabetes, hypertension, obesity, and colon cancer –in addition to their better-known association with aging. This meeting catalyzes chemical senses research for human health